Novel approaches for the treatment of autoimmune disease

PROJECT SUMMARY/ABSTRACT
The overall goal of this project is to develop a novel therapeutic for the treatment of immune-
mediated thrombotic thrombocytopenic purpura (iTTP). iTTP is an acute, life-threatening disease
that without treatment, leads to a >90% mortality rate. It is caused by deficiency of a disintegrin
and metalloprotease thrombospondin type 1 motif, member 13 (ADAMTS13), which is a protease
that regulates the levels of ultra-large aggregates of von Willebrand factor (VWF). Such VWF
aggregates bind to platelets, resulting in blood clots. Consequently, ADAMTS13 deficiency leads
to microthrombus formation in arterioles and capillaries, and iTTP is characterized by hemolytic
anemia, thrombocytopenia and organ damage, with possible severe cardiac, renal, neurological
and gastrointestinal effects.
For iTTP, ADAMTS13 deficiency is caused by autoantibodies specific for this protease.
Current treatments are therefore directed towards reducing the levels of these antibodies by
plasma exchange and the use of general immunosuppressants (corticosteroids, rituximab). In
addition, a bivalent nanobody (caplacizumab) that inhibits VWF-platelet interactions has recently
been approved to treat iTTP. Despite treatment, however, relapses occur in about 30-50% iTTP
patients. Further, the treatments can have adverse effects such as severe bleeding events that
can be fatal (caplacizumab) and/or increased risk of infection due to general immunosuppression.
Rituximab also has a slow onset of action and is used in combination with plasma exchange.
Consequently, there is a need to develop therapies for iTTP that have rapid effects and high
specificity for the causal agent of disease, namely the autoantibodies.
The goal of the Phase I project was to generate proof-of-concept by designing a Seldeg to
target ADAMTS13-specific antibodies, and show the suitability of the Seldeg for clinical
development using in vitro assays. In this Phase II application, we propose to progress the Seldeg
along the development path, using a combination of in vitro analyses to further characterize the
Seldeg and studies in animal models. The Specific aims are:
1. To carry out drug development and testing of the ADAMTS13-Seldeg using in vitro analyses.
2. To analyze the in vivo behavior of the ADAMTS13-Seldeg and targeted autoantibodies.
The proposed approach could be transformative for the management of iTTP, and also has
relevance to the use of Seldeg-based strategies for multiple other clinical settings where
pathogenic antibodies cause disease.

Public health relevance
PROJECT NARRATIVE Current treatments for immune-mediated thrombotic thrombocytopenic purpura (iTTP), that is caused by autoantibodies specific for a protein called ADAMTS13, are generally immunosuppressive and/or are associated with adverse side effects. In this application we propose to develop a novel treatment that selectively removes the autoreactive antibodies which are involved in the disease process, without affecting the levels of other antibodies that are important for protection against infectious agents such as bacteria and viruses. This approach has the potential to be transformative for the management of iTTP.